Parental Influences on Tobacco Use among Sexual Minority Young Adults in a New Market and Policy Landscape

PROJECT SUMMARY/ABSTRACT
Young adulthood (YA) is a critical period for engaging in risk behaviors, including tobacco use, and establishing lifestyles
with long-term health implications. The landscape of tobacco use in the US has changed in recent decades, with decreases
in cigarette use coupled with increases in the use of alternative tobacco products (ATPs; electronic cigarettes, cigars,
smokeless tobacco, hookah). These complexities are further compounded by an evolving tobacco policy context and
increases in polytobacco use. The use of these products disproportionately impacts vulnerable subgroups, including sexual
minority YAs. Identifying mechanisms accounting for sexual orientation disparities in traditional and ATP use is critical
for informing interventions to reduce use and disparities. However, there is a substantial gap regarding the mechanisms
that explain these disparities. Important predictors of YA tobacco use are parenting behaviors and mental health problems,
which may have particularly strong influences for sexual minority YAs, given the multitude of community and social
impacts on tobacco use during this time. This F32 application aims to catalyze Dr. Romm’s achievement of her career
goal – to establish an independent research program devoted to elucidating multilevel determinants of health-risk
behaviors among vulnerable adolescent and YA populations and inform interventions to prevent and reduce such
behaviors. This proposal capitalizes on Dr. Romm’s existing skills and experience, and provides 1) training in advanced
multilevel behavioral theories, health disparities, and intervention research; 2) mentored support for her professional
development; and 3) resources for mentored and independent research to advance novel research at the intersection of: a)
a particularly vulnerable population – sexual minority YAs; b) multilevel mechanisms that explain sexual orientation
disparities in YA tobacco use; and c) use of both traditional and ATPs, highly relevant within today’s evolving tobacco
context. More specifically, the training will directly enhance the skills and expertise Dr. Romm requires to execute the 3
research aims, to: 1) examine sexual orientation (distinguishing heterosexual, bisexual, and gay/lesbian) in relation to
changes in use of traditional and ATPs among YA men and women; 2) document differential associations between
parenting behaviors and tobacco use among male and female sexual minority versus heterosexual YAs; and 3) identify
mediators and moderators of the impact of parenting behaviors on tobacco use behaviors among sexual minority versus
heterosexual YAs. The proposed research leverages a developmental framework, sociocognitive theory and minority
stress theory, and multiple research methods, including a 1-year longitudinal survey design and qualitative interviews.
Ultimately, this proposal will advance a high-impact career of a promising young investigator and inform family-based
interventions to reduce sexual orientation disparities in YA tobacco use within the rapidly evolving tobacco landscape.

Public health relevance
PROJECT NARRATIVE This F32 application aims to catalyze Dr. Romm’s achievement of her career goal - to establish an independent research program devoted to elucidating multilevel determinants of health-risk behaviors among vulnerable adolescent and young adult populations and inform interventions to prevent and reduce such behaviors. This proposal entails: 1) training in advanced multilevel behavioral theories, health disparities, and intervention research; 2) mentored support for professional development; and 3) resources for mentored and independent research to advance her research at the intersection of: a) a particularly vulnerable population – sexual minority young adults; b) multilevel mechanisms that explain sexual orientation disparities in young adult tobacco use; and c) use of both traditional and alternative tobacco products, highly relevant within today’s evolving tobacco context. The proposed research leverages a developmental framework, sociocognitive theory, and minority stress theory; combines multiple research methods, including longitudinal surveys and qualitative interviews; and positions Dr. Romm for related intervention research.